Annual Meeting of the Society for the Study of Reproduction

PROJECT SUMMARY
The Society for the Study of Reproduction (SSR) holds an annual scientific meeting
attended by ~900 basic and clinical researchers, teachers, and undergraduate, graduate,
and postdoctoral trainees, from universities, medical schools, research institutes, and
clinics in the U.S. and more than 30 other countries. The three-fold goals of every
meeting are (1) to present state-of-the-art research in biology underlying and associated
with reproduction, fertility, and development; (2) to provide an environment that
encourages scientific dialogue, collaboration, and innovation and (3) to provide a
meeting program, setting, and culture that promotes professional development of
trainees and early-stage investigators. Each meeting consists of plenary and state-ofthe-art lectures by world-class scientists, and 20-25 concurrent sessions (with 2-4
speakers in each) over 3 and a half days that focus on subjects of interest to scientists
in biomedical, clinical, and veterinary and animal science, as well as those who
concentrate on wildlife conservation. Oral and poster presentations (typically 50-100
and 500-600, respectively) highlight research contributions by scientists from a range of
career stages, but with a special focus on trainees and early career investigators. These
presentations are selected from submitted abstracts, based on quality review by the
Program Committee. Abstracts submitted for trainee award competitions also are
reviewed by the SSR's Awards Committee. This grant application is a renewal of our
longstanding SSR annual meeting grant and will support the SSR Annual meetings in
2023 (Ottawa, CA), 2024 (Dublin, IE), sites for 2025-27 are yet to be determined.

Public health relevance
PROJECT NARRATIVE The SSR annual meeting provides a venue, scientific program, and environment designed to stimulate learning and collaboration and engage attendees in critical scientific discussion with the goal of generating new knowledge leading to solutions in reproductive medicine, public health, agriculture, and conservation that will benefit humans and animals. A critical goal of our meeting is to enhance training and mentoring of all trainees and support them as they progress through their careers.